Integrating Genomic Risk Assessment for Chronic Disease Management in a Diverse Population

ABSTRACT
This bioethics focused research proposal builds upon pilot data gathered through
eMERGE site-specific ELSI research. That research compared rural and urban Alabama
Genomic Health Initiative (AGHI) participants from African and European ancestry on a number
of issues related to obstacles and attractions to participation in genomic research. Pilot data
suggested interesting and stark differences in trusted sources of information among these
populations, warranting deeper investigation. In this study, we will focus our investigation more
narrowly on trusted sources of information, while simultaneously expanding our recruitment to a
national audience.
Utilizing both qualitative focus group and quantitative survey data, we will explore key
sources of medical information trusted by individuals from White and African American racial
backgrounds, including the role of a variety of community leaders and spokespersons, as well as
the role of word-of-mouth, venues for dissemination of information, and effective messaging
platforms (e.g., religious organizations, social media, television or radio, etc.). In addition, we will
identify key contextual factors most salient in establishing trust for participation in genomic
screening within each population. Findings will be confirmed using a quantitative survey, which
will also look for regional contexts among both White and African American participants. Finally,
we will determine whether there are statistically significant differences in trusted sources of a)
medical and b) genomic screening information. We will do this through a quantitative survey
developed on the basis of preliminary focus group findings.
The results of this study will significantly enhance future genomic research by contributing
to the recruitment infrastructure necessary to fully diversify participant demographics. The data
from this study will result in two deliverables. First, data will be analyzed and disseminated to the
larger eMERGE consortium, as well as through publication in a peer-reviewed scientific journal.
Second, the data and methodology will provide a basis for development of an R21 or R01 seeking
to identify contextual factors influencing trusted sources of information among Asian, Hispanic,
Native American, and other demographic groups with specific cultural norms.

Public health relevance
PROJECT NARRATIVE This project will increase understanding of trust and mistrust in sources of medical information and genomic screening. It will provide necessary information to improve communication and genomic screening recruitment of African Americans in the United States.